Helicase Mechanism and G-Quadruplex Signaling

Project Summary
The MIRA will support the productive, long running Research Program in the Raney lab. The mechanism and
regulation of DNA helicase activities are being addressed in Project 1 whereas signaling mechanisms for G-
quadruplexes follows in Project 2. Helicases are molecular motor proteins that transduce chemical energy from
ATP hydrolysis into mechanical energy capable of unwinding dsDNA, translocating on ssDNA, unfolding
quadruplex DNA and remodeling protein-DNA complexes by moving protein along DNA. Two percent of the
yeast genome encodes helicases, and the human genome encodes over 100 helicases. Each metabolic pathway
involving nucleic acids such as replication, transcription, repair, translation, and other processes requires the
activity of one or more helicases. Many cancers are correlated with helicase mutations. Many viruses such as
SARS2, ZIKA, West Nile, Ebola, and many others encode one or more helicases that is essential for viral
replication, therefore helicases can be targets for-cancer and anti-viral development. The over-arching question
for Project 1 is “what is the mechanism utilized by a helicase to perform multiple functions?” We are utilizing the
yeast Pif1 helicase to address this question and others. Pif1 is in the largest superfamily of helicases. The
biochemical and biological studies needed to determine the underlying mechanisms are facilitated in the yeast
system. Pif unwinds duplex DNA, unfolds G-quadruplex DNA (G4DNA), translocates on single-stranded DNA,
and remodels DNA bound to proteins by moving the proteins. Experiments here will address the hypothesis that
these activities can be understood within a unified mechanism. A major gap is the lack of a consensus for how
energy from ATP hydrolysis is transduced into molecular motion that can be used to unwind dsDNA or unfold
quadruplex DNA. Another major gap includes the lack of knowledge of how helicases fit into macro-molecular
machines such as the mitochondrial DNA replication holoenzyme. We have identified key amino acids that
strongly control energy transduction through novel helicase motifs and we will determine the mechanism of these
amino acids. Project 2 will address the over-arching question of “what is the function of the guanine-rich DNA
sequences that can fold into G-quadruplex structures (G4DNA)?” These sequences clearly play important roles
in replication, transcription, translation, and repair because they appear in highly disproportionate levels in the
genome including promoters, telomeres, and mitochondrial DNA. In Project 2, we will determine whether G4DNA
is excised from the genome through an excision repair mechanism. DNA repair mechanisms often remove
damaged DNA from the genome. Our hypothesis is that G4DNA is excised, resulting in a signaling molecule
that triggers a cellular response affecting many pathways including stress granule formation. We will test this
hypothesis through a variety of structural, molecular, and cellular approaches. Initially, we will perform screens
for nucleases that excise G4DNA. Projects 1 and 2 will continue to have a strong and lasting impact through the
work in this Research Program.

Public health relevance
Project Narrative Helicases are enzymes required for nucleic acid metabolism including transcription, translation, and DNA repair. Guanine-rich sequences can fold into stable structures that are capable of regulating gene expression. The over-arching goal for this Research Program is to understand mechanisms of helicases (project 1) and G- quadruplexes (project 2) that might lead to cancer.